Functional crosstalk between the Fanconi Anemia and ATRX/DAXX histone chaperone pathways

PROJECT SUMMARY
The Fanconi Anemia (FA) pathway functions to maintain genomic stability and is crucial for the repair of DNA
interstrand crosslinks (ICLs). During ICL repair, the central FANCD2 protein promotes the recruitment of
downstream factors such as BRCA2[FANCD1] and RAD51[FANCR] that are crucial for homologous
recombination (HR) repair of DNA double stranded breaks (DSBs), including those generated during ICL
removal. Previous studies from our laboratory and others showed that FANCD2 has additional roles in
promoting the HR-dependent recovery of hydroxyurea (HU) or aphidicolin (APH) stalled replication forks.
Intriguingly, we recently identified a new constitutive FANCD2 interactor named ATRX (Alpha Thalassemia
Retardation Syndrome X-linked). ATRX, in complex with DAXX (Death Domain-Associated Protein 6), acts as
a chromatin remodeler and histone H3.3 chaperone that regulates chromatin compaction. While ATRX was
originally not considered to be involved in mechanisms of genome maintenance, recent studies showed that
acquired ATRX gene defects are strongly associated with a subset of cancers that exhibit excessive genome
instability. However, the underlying mechanisms of ATRX-dependent genome stability are not known.
To elucidate a potential functional cross-talk between the ATRX and FANCD2 pathways, we generated
isogenic human knockout cell lines lacking ATRX, FANCD2, or both. We found that ATRX and FANCD2 form a
constitutive protein complex with the MRE11-RAD50-NBS1 (MRN) nuclease. This complex acts as a functional
unit to promote HR-dependent replication fork recovery and the repair of directly inducible DNA DSBs.
Simultaneously, and paradoxically, we also observed that ATRX and FANCD2 gene defects had a synergistic
effect on cellular ICL sensitivities. Based on our observations, we hypothesize that ATRX cooperates with
FANCD2 and MRN to promote HR-mediated repair mechanisms, but also possesses additional activities that
contribute to DNA ICL removal in the absence of a functional FA pathway.
To test our hypothesis, we propose three Specific Aims:
1) Elucidate the molecular and structural makeup of the ATRX-MRN-FANCD2 protein complex
2) Determine molecular mechanisms of ATRX/FANCD2-mediated replication fork recovery.
3) Dissect FANCD2-dependent and -independent roles of ATRX during DNA ICL repair.

Public health relevance
PROJECT NARRATIVE The Fanconi Anemia (FA) pathway has crucial roles during DNA replication and repair. We identified a new physical and functional FA pathway interactor named ATRX (Alpha Thalassemia and Retardation X-linked factor) and found that ATRX shares some, but not all, of the known FA pathway functions. We will explore the molecular mechanisms underlying these observations and test whether our findings can also provide an explanation for the effects of cancer-associated, sporadic ATRX mutations.